Developing Imaging Biomarkers of Oral Squamous Cell Carcinoma Response to Immunotherapy

Oral squamous cell carcinomas (OSCC) are aggressive malignancies that are often diagnosed at advanced
stages in patients and therefore associated with a poor prognosis. Recently, immune checkpoint inhibitors
have received regulatory approval for advanced OSCC patients. Although some OSCC patients exhibit
remarkable response to immunotherapy, overall response rates remain low. Identifying an early noninvasive
biomarker of immunotherapeutic efficacy could therefore have a significant impact in patient selection. In this
regard, our laboratory has been investigating the potential of ultrasound (US) with spatially co-registered
photoacoustic imaging (PAI) to monitor OSCC progression and potentially predict response to immunotherapy.
Using a novel, orthotopic, immunocompetent model of OSCC (RP-MOC1) we have demonstrated the ability of
US-PAI to monitor functional vascular changes during OSCC progression. In preliminary studies, we have also
observed observed a significant association between early vascular response to immunotherapy detected by
US-PAI and long-term treatment outcomes. Based on these exciting preliminary observations, it is our
hypothesis that early vascular response to immunotherapy detected by US-PAI can serve as a biomarker of
OSCC progression and immunotherapeutic efficacy. To test this hypothesis, we will examine the spatio-temporal correlation between changes in tumor vascularity and T-cell profiles (Aim 1) and evaluate the ability
of US-PAI based hemodynamic response to prognosticate OSCC response to immunotherapy (Aim 2).
Successful completion of the proposed studies could enable further development of US-PAI as a novel
approach to guide patient selection, monitor immunotherapy, and predict outcomes.

Public health relevance
Oral cancers are aggressive malignancies that are associated with high rates of morbidity and mortality in humans. While remarkable benefits have been observed for oral cancer patients receiving immunotherapy, this response is only seen in a fraction of patients. The overall objective of this application is to develop and validate noninvasive biomarkers to predict patient outcomes in response to immunotherapy using a novel hybrid imaging technique.